Dynamics of Ligand Binding and Protein Kinase Regulation

Abstract
This application seeks supplement support to replace a frequently failing and costly to maintain
chromatography system (FPLC, Amersham Pharmacia) from 2010 with an up to date FPCL instrument.
Virtually all work performed in our lab requires proteins purified by a FPLC system. Our current system is
more than 10 years old, no longer supported by the manufacturer, frequently failing and incurring high
costs of repair from third party suppliers. Since purified proteins are crucial for our work, we rely on this
type of instrumentation and request a new instrument (Akta pure 25 L) with essentially the same
capabilities as the existing instrument.

Public health relevance
Project Narrative This project is relevant to public health because the understanding of how conformational dynamics affect the regulation, allosteric modulation, ligand binding kinetics and drug specificity of protein kinases is expected to increase understanding of disease-relevant kinase signaling pathways. The project aims to advance this fundamental knowledge and to develop macrocyclic therapeutics.